External Network Core

Project Abstract (External Network Core)
Opportunities for scientists to critique and learn from each other’s research, and to sustain ongoing
multidisciplinary collaborations and synergies across research groups and studies, can strengthen the rigor of
research and accelerate the development of new knowledge. The External Network Core of the Center to
Accelerate Population Research in Alzheimer’s (CAPRA) aims to create those opportunities for
multidisciplinary collaboration and interaction by developing networks of scientists focused on high-priority
topics for policy and healthcare research related to AD/ADRD. Research in this area often takes advantage of
the growing collection and greater availability of administrative (e.g., Medicare, Medicaid) and population-
based survey data (e.g., the Health and Retirement Study international family of studies) on cognitive function,
and other novel data sources in the US and internationally. While these data are becoming more available,
their complexity and the speed at which AD/ADRD research is moving creates challenges for using them to
address important and timely questions. Development of networks of investigators from different institutions will
allow for cross-fertilization, generation of new ideas, and shared learning on how to apply sound methods
efficiently. The External Network Core is designed to use as a foundation the ongoing collaborations, expertise,
and infrastructure at the University of Michigan and recruit investigators who are junior or transitioning into
AD/ADRD research. Within the overarching theme of CAPRA, which is to develop science that informs
government and healthcare organization activities that will address the negative effects of dementia on
individuals and the population, four external networks will be established, each addressing a critical scientific
area: Diffusion of New AD/ADRD Diagnostics and Drugs; End-of-Life Treatment and Care across Systems and
Countries; Disparities and Cardiovascular Risk in Dementia; and Quality Prescribing in Alzheimer’s Disease.
We will create and sustain these research networks in a cost-effective way by using at-distance on-line and
videoconferencing collaboration strategies for regular and ongoing follow-up after initial in-person meetings.
The External Network Core will also collaborate closely with and leverage the activities of the CAPRA
Research Resources Core for dissemination of ongoing research activities of the External Network members.
In addition, the External Network Core will work closely with the Pilot Core to solicit and fund pilot projects from
External Network members, especially junior faculty members. The External Network Core will advance
science related to the demography, economics and health services research in AD/ADRD by giving
investigators, expert and newly joining the field, the benefits of sharing their expertise, opportunities for
collaboration and cross-fertilization that stimulate novel and impactful future studies.